Supplement to U01CA260469

Project Summary
African Americans develop and die from SARS-CoV-2 infection more than any other racial group in the United
States, including in majority African American cities such as Flint, Michigan. SARS-CoV-2 disparities stem from
many interconnected causes. Yet, connections to inflammatory biological processes in COVID-19 disparities
remain largely unknown. Evaluating inflammatory responses can be facilitated by SARS-CoV-2 antibody
testing, which can be used to identify and compare inflammation among those with and without confirmed
SARS-CoV-2 infection, and to conduct cross-race comparisons of inflammatory factors. However, African
Americans will be reluctant to partake in conventional antibody testing programs due to medical mistrust and
experiences with racism that are salient in the COVID-19 era. There is thus an urgent need to develop and
deploy culturally-relevant communication and antibody testing programs. Our long-term goal is to identify and
reduce unjust COVID-19 racial disparities. The immediate objective is to better encourage understanding and
uptake of SARS-CoV-2 antibody testing. The central hypothesis is that African-Americans will be receptive to
antibody testing when benefits and limitations are communicated in a culturally effective manner, and when
non-invasive salivary collection methods and assays are used. Our rationale is that combining culturally
effective health communication with salivary testing will reduce mistrust and promote uptake that can lead to
better grasping the role of inflammation in COVID-19 disparities. Our aims are to 1) develop and compare
effects of a general versus culturally-targeted video about antibody testing on African American and White Flint
residents’ antibody testing attitudes and uptake; 2) identify and compare effects of a general versus culturally-
targeted video on activation of medical mistrust and racism-related cognition among African Americans when
considering antibody testing; 3) measure and identify multi-analyte inflammatory biomarker profiles among Flint
Registry enrollees who complete salivary antibody testing and compare inflammatory biomarker profiles by
race and antibody status. In collaboration with clinical and community partners, we will prepare and evaluate
general and culturally-targeted video tutorials about SARS-CoV-2 antibody testing. These brief videos will be
distributed to the Flint community through the Flint Registry – a highly visible local health resource exchange.
In collaboration with leading salivary bioscience experts, we will furnish an opportunity to engage in at-home
salivary antibody screening – a non-invasive route to antibody testing that is highly suited to disparities-
oriented COVID-19 research. The proposed research is innovative and significant in highlighting that culturally-
targeted communication and non-invasive antibody testing are vital to propelling disparities-oriented
inflammatory COVID-19 research. Knowledge to be gained includes video tutorials and insights about
community-facing salivary collection that can be immediately disseminated across SeroNet to better promote
including racial monitories in ongoing studies of inflammation and antibody testing.

Public health relevance
Project Narrative The proposed project is relevant to public health because communicating effectively to African Americans about SARS-CoV-2 antibody testing, as well as providing an option of at-home non-invasive antibody screening in saliva, could enhance uptake of antibody testing among African Americans – a racial minority population that has been especially impacted by the COVID-19 pandemic. Greater uptake of antibody testing among African Americans is also critical to better grasping how inflammatory process contribute to racial disparities in SARS-CoV-2 infection and recovery. The proposed research is relevant to the NCI mission to conduct and fund research that improves early detection and diagnosis and reduces cancer-related disparities.